Roles of TIMELESS in oncogene-induced senescence and oncogenic transformation

PROJECT SUMMARY
Oncogenic stimuli in early cancerous lesions, such as driven by RAS mutations, triggers oncogene-induced
senescence (OIS), which acts as a barrier to prevent malignant transformation. Establishment and
maintenance of OIS is dependent on the sustained DNA damage response (DDR) that stems from aberrant
DNA replication and accumulation of DNA replication stress. Hence, progression to malignancy requires DDR
inactivation and escape from senescence, which, when accompanied by genome instability, accelerates
carcinogenesis. For instance, gains in RAS are prevalent in metastatic prostate cancer, suggesting that this
aberration may be a driver of the prostate cancer progression and aggressiveness. However, the precise
nature of oncogene-induced replication stress and how it affects replication fork integrity remains unclear.
While recent studies have highlighted replication fork reversal as a means to stabilize stressed forks and
promote fork restart, whether oncogenic signaling disrupts fork protection mechanisms, thereby culminating
into fork destabilization remains unclear. Furthermore, whether there exists a distinct program that transmits
upstream oncogenic signaling to a replication fork to cause fork instability is an important outstanding question.
These knowledges are essential for understanding how premalignant lesions restrain from developing cancer,
which would help design therapeutics that sensitizes cells to oncogene-induced replication stress. The goal of
this project is to explicate the mechanism that links oncogene-induced replication stress to DNA replication fork
integrity. We propose that TIMELESS (TIM) in the fork protection complex, an integral constituent of the
replisome, is a key determinant of modulating OIS and transformation. Our preliminary studies reveal that OIS
induced by HRASG12V is accompanied by TIM downregulation in non-transformed cells, which is mediated by
PARP1-dependent poly(ADP-ribosyl)ation onto TIM, a novel TIM post-translational modification that primes
TIM for proteasomal degradation. Conversely, TIM is upregulated in OIS-bypassed clones and in the KrasG12D
prostate cancer model, indicating that TIM activity at stalled forks may determine the responses to oncogene-
induced replication stress and resistance to OIS. We thus hypothesize that deprotection of stalled forks via TIM
downregulation is an unappreciated oncogene-induced mechanism that contributes to DNA replication fork
instability to cause OIS. To test this idea in prostate cancer, we will 1) determine how deprotection of stalled
forks is linked to senescence induced by HRASG12V and other oncogenes in cellular models; 2) explicate the
mechanism of TIM downregulation mediated by RAS-PI3K-PARP1 proteolytic signaling; 3) determine the role
of TIM in bypassing senescence and promoting tumorigenesis using KrasG12D-driven prostate cancer organoid
and mouse models. We expect to reveal how modulation of TIM, or stalled fork integrity in general, potentiates
OIS and exerts a selection pressure to bypass OIS for transformation. This knowledge will help develop TIM
gain-of-function as a target to exploit OIS for suppressing tumorigenesis.

Public health relevance
PROJECT NARRATIVE By unraveling the molecular mechanism through which DNA replication fork protection determines oncogene- induced senescence and oncogenic transformation, this study will provide new insight into how disruption of replisome activity is linked to oncogene-induced replication stress and fork instability. Fundamental knowledge on the signal transduction pathways essential for this fail-safe tumor suppressive barrier will help develop a strategy that exploits the replication vulnerability of cancer cells as a new therapy and augment the effort to identify potential biomarkers relevant to DNA replication stress in cancer patients.